CTSA Postdoctoral T32 at University of Minnesota

The mission of the Clinical and Translational Science Institute (CTSI) postdoctoral T32 Program is to contribute to the nation’s biomedical workforce by training an interdisciplinary pool of scientists in clinical and translational science (CTS) and leadership. We will meet this mission by developing, implementing, and continually improving a training program for postdoctoral trainees (Scholars) that integrates a mentored research experience with an individualized curriculum combined with professional development activities highlighting our institutional strengths in community engagement, data science, team science and effective communication skills. The UMN CTSI T32 Program is built upon our current successful Translational Research and Career Development (TRACT) TL1 Program, which guided the development of early-stage CTS researchers over the past 4 years. Through personalized mentorship, coursework, seminars, and other tools, the TRACT program has guided 6 postdoctoral Scholars along a rigorous path of professional development in CTS. Moving forward, the new UMN CTSI T32 Program’s mission is to educate and train Scholars from across the UMN system in the fundamentals of CTS through a 2-year comprehensive yet individualized program. We will recruit and train 3 cohorts of 4 postdoctoral Scholars from across a variety of disciplines at the UMN. UMN CTSI T32 will provide a research experience with mentors trained in evidence-based mentoring, focusing on collaboration and communication with community members throughout the research process, inclusive of a Community Mentor and team science across the UMN ecosystem. The UMN CTSI T32 will also include near-peer learning experiences with other CTSI program Scholars as well as provide education and opportunities for a variety of career paths. The UMN CTSI T32 will use a comprehensive and adaptive evaluation plan for rigorous programmatic assessment and continuous quality improvement to maximize the training experience. The principal Scholar outcome is to have a deep knowledge in the science of translation beyond translational research. Another key Scholar outcome is an understanding of the importance of, and key strategies for, building truly collaborative interdisciplinary teams composed of people from a variety of scientific backgrounds whose collective roles synergistically optimize the advancement of diagnostics, therapeutics, and clinical interventions that improve health. Other outcome measures include the ability to communicate with other scientists and nonscientific audiences and collaborators through our intensive formalized training in communicating science, and the ability to effectively engage with communities through intensive community engagement training including a Community Mentor Program. Programmatic outcomes include the development of training modules and workshops on the most effective community engagement and communications strategies exportable to the national CTSA consortium.

Public health relevance
UMN Postdoctoral Narrative The Clinical and Translational Science Institute (CTSI) postdoctoral program trains the next generation of scientists to speed application of scientific discoveries to improve human health. Scholars will participate in 2 years of mentored research, individualized curriculum, and professional development activities highlighting our institutional strengths in leadership, community engagement, data science, team science and effective communication skills.